Core Grant for Vision Research

SUMMARY – OVERALL COMPONENT
This P30 renewal proposal requests continued funding to support the operation of six resource modules within
the Vision Institute (VI) at Mercy Pavilion of the University of Pittsburgh. The VI provides a home base for the
basic and clinical vision research for ~30 vision scientists in four departments at the University of Pittsburgh
and Carnegie Mellon University. The innovative work of these scientists is advancing our knowledge of corneal
cell biology and regeneration; glaucoma (imaging, trabecular meshwork stem cell biology and stem cell-based
therapeutics, and ocular biomechanics); retinal and RPE development, degeneration and regeneration; visual
neuroscience; ocular infectious disease; ocular immunology; the ocular microbiome; and visual/cortical
prosthetics, among other areas. We are a collegial, collaborative, and productive group of researchers;
nineteen of our vision scientists hold twenty-two qualifying NEI-funded R01 grants. In addition, three vision
scientists hold four vision-related R01 grants that are funded through other NIH institutes, two vision scientists
hold U01 grants from the NEI, and one vision scientist holds a K99 award from the NEI. The remaining
participating faculty in the Core Grant either hold significant vision-related grants from foundations or are new
investigators and are generating pilot data for submission of their first NEI/NIH R01 grants. Importantly, many
of these new investigators have already been successful in obtaining seed grants from vision research
foundations to support their research programs. Over the last 35 years, the Core Grant for Vision Research
has played a central role in enhancing the NEI-funded research of our participating faculty and supporting new
faculty in establishing their vision research programs. In this renewal application, the Core Grant will continue
to provide resources, services, and technologies that are essential to the success of the vision research efforts
underway at the University of Pittsburgh and Carnegie Mellon University. The Core Grant enhances the
overall vision research environment in Pittsburgh by: 1) providing core resources that are critical to the success
of vision scientists; 2) enhancing collaboration among vision scientists in the Pittsburgh area, 3) aiding in the
recruitment of new vision scientists to Pittsburgh, and 4) providing intellectual and technical support for the
advanced training of students and fellows in vision sciences.

Public health relevance
NARRATIVE – OVERALL COMPONENT The Core Grant for Vision Research supports the work of a diverse group of vision scientists in the Pittsburgh area conducting research on vision, infectious disease, causes of blindness, and developing new therapies to prevent blindness. The grant provides critical support to NEI-funded investigators, and it supports pilot studies that can be incorporated into new NIH/NEI R01 applications from new investigators or established investigators moving into vision research. The services and equipment provided by this grant allow our vision scientists to integrate diverse scientific approaches into their vision research projects and thereby enhance their overall impact.